Hospital Consolidation: Reducing access for the poor?

PROJECT SUMMARY
Hospitalmergers and acquisitions (M&As) increase concentration in hospital markets.In 2016, 90% of
Metropolitan Statistical Areas were considered “highly concentrated.”5 Much of the literature on hospital M&As
focuses on the effects on private prices and hospital cost reductions.1,6–14 However, despite growing concern
from federal and state regulatory agencies,2,3,15–17 little is known about how M&As affect access to care,
especially for low-income Medicaid and uninsured patients, who most often experience access challenges.18–21
In an effort to improve efficiency and reduce costs, consolidating hospitals may eliminate a service line (i.e.,
whether a service is offered) at one of the M&A hospitals if it is provided at the other, particularly if the service
line is unprofitable.22,23 This could reduce local capacity to provide clinically important services and, in turn,
patients' geographic access. In addition, hospital MAs often result in increased private reimbursement.1,24,25
The economic theory of price discrimination suggests that hospitals seeking to maximize profits may reduce
provision of care to Medicaid and uninsured patients. However, the theory of cross-subsidization suggests that
public and not-for-profit hospitals would instead use increased profits from private patients to further subsidize
care of Medicaid and uninsured patients and unprofitable services in line with their mission.26 These theories
suggest the need to examine M&A-related access changes on both an extensive margin (i.e., whether a
service is provided) and intensive margin (i.e., quantity of services provided).This study will examine M&A-
related changes in hospital service provision and access using national data on hospital characteristics from
the American Hospital Association and Centers for Medicare & Medicaid Services along with discharge-level
data from the Healthcare Cost and Utilization Project State Inpatient Databases for select states. First, I will
determine whether hospitals reduce provision of select inpatient and outpatient service lines after a M&A,
focusing on service lines that are generally unprofitable due to high utilization by Medicaid and uninsured
patients, such as substance use, psychiatric, obstetric, and trauma services. Next, I will estimate the extent to
which Medicaid and uninsured inpatient admissions change following a M&A, focusing on elective admissions.
While regulations ensure access to emergency care, hospitals are not obligated to provide Medicaid and
uninsured patients access to elective inpatient services, such as knee replacements and bariatric surgery.
Thus, changes in elective admissions may best reflect hospitals' efforts to limit or expand care. Building on
these results, I will look at whether M&As result in shifts of Medicaid and uninsured patients to neighboring
hospitals and reduce overall access at the regional scale for these patients. This study addresses an important
knowledge gap by examining the impacts of M&As on inequitable access among uninsured and Medicaid
patients, a group that spans several AHRQ priority populations, including people with low-incomes, racial and
ethnic minorities, women, children, and people with disabilities.

Public health relevance
PROJECT NARATIVE Hospital consolidation continues at a rapid pace without empirical evidence of how mergers and acquisitions affect access to care, particularly for low-income populations. Federal and state regulatory agencies are expressing concern about hospital consolidation exacerbating disparities in access, but policymakers lack the evidence needed to ground policies to address these concerns. The proposed study aims to address this gap by examining the extent to which hospital mergers and acquisitions have impacted access to care for Medicaid and uninsured patients by examining changes in hospitals' provision of service lines (i.e., whether a service is offered) commonly used by these patients, changes in inpatient admissions, and whether changes in service provision at consolidating hospitals affect regional access to care.